Targeted Nanotherapies for the Treatment of Brain Disorders

Project Summary
The delivery of small molecule therapeutics across the blood brain barrier (BBB) is difficult, making the
development of therapies for neurological diseases very challenging. Even if the drugs or nanoparticles cross
the impaired BBB following brain injury, targeting key cells involved in the brain diseases, such as, neurons
present significant challenges. Targeting neurons is specifically complex since they are far lower in number and
less phagocytic in nature compared to the glial cells. Moreover, neurons exist in a variety of types that perform
specific functions in the brain which makes targeting specifically the injured neurons more difficult. We have
designed and developed a novel tailor-made 2-deoxy-D-glucose (2DG) based glycodendrimer nanoplatform
(2DG-D) that addresses these challenges by targeting and delivering drugs to neurons selectively at the site of
brain injury.
Our preliminary data suggest that the fluorescently labeled 2DG-D demonstrates neuronal targeting
and specifically localizes within the neurons across the BBB at the site of injury in the brain from systemic
administration in a mouse model of pediatric traumatic brain injury (TBI). The 2DG-D technology is designed to
selectively deliver high payloads of drugs to affected neurons and microglia across the BBB, and to
simultaneously achieve in vivo stability, high water solubility, ease of scalability, and flexibility in single or
multiple drugs delivery. Our unique platform builds on our expertise in designing clinically relevant
nanomaterials for drug delivery applications. We further show that a single systemic dose of a conjugate of
2DG-D and pioglitazone (Pio) a PPAR- γ agonist (2DGD-Pio) improves behavioral outcomes and
neuroinflammatory responses in a pediatric mouse model of TBI. Pio is an anti-diabetic drug being widely
investigated for brain diseases, including TBI. However, its poor aqueous solubility and peripheral side-effects
are a concern that can be addressed using 2DGDN mediated targeted delivery. The goal of this R01 proposal
is to develop a neuron-targeting 2DGD-Pio conjugate and validate the efficacy in pediatric TBI model to treat,
preserve, and restore neuronal function, with significant implications for other brain disorders. Our ultimate
long-term objective is to develop scalable, systemic 2DGD-drug therapies with improved efficacy and reduced
systemic side effects that can be used not only for TBI but other brain diseases as well. We will achieve our
goal through the following three aims: Aim 1: demonstrate reproducible synthesis and evaluate mechanism of
uptake of 2DG and 2DGD-Pio conjugates; Aim 2: assess in vivo biodistribution, pharmacokinetics and toxicity
of 2DG and 2DGD-Pio; and Aim 3: short and long-term efficacy of 2DGD-Pio conjugate in a TBI mouse model.

Public health relevance
Project narrative The proposed research is relevant to public health because it explores the development of new 2-deoxy glucose dendrimer-based nanomedicines for intracellular drug delivery to neurons in the region of brain injury for the treatment of traumatic brain injury. The proposal presents a nanotechnology-based approach to specifically target and deliver drugs to neurons, the key cells implicated in many brain disorders, increasing drug efficacy, and reducing side effects. Therefore, this work is relevant to the mission of NIH relating to treating neurological diseases.